DENDRITIC AND T CELLS IN ANTI-BACTERIAL lg RESPONSES

Streptococcus pneumoniae (Pn)is an extracellular bacterium that is a major cause of global morbidity and mortality. Systemic adaptive immunity to Pn is mediated by antibody, especially IgG specific for the capsular polysaccharide (PS),but also for bacterial proteins. Our long-term goal is to elucidate the cellular mechanismsthat underlie the distinct differences that exist between in vivo anti-PSand anti-protein Ig responses to intact Pn, as a prerequisite to the development of improved vaccines.In contrast to the current dogma, based on using purified PS antigens, that IgG anti-PS responses are T cell-independent, we demonstrated that the IgG anti-PS response to intact Pn is heavily dependent on CD4+ T cells but nevertheless, still exhibits striking differences in kinetics, generation of memory, and the functional roles of dendritic and T cells relative to the co-induced anti-protein response. In light of these data, the central hypothesis that underlies our proposed research is that differential B cell receptor signaling and/or involvement of functionally distinct B cell subsets are the key parametersthat distinguish physiologic anti-PS and anti-protein Ig responses. We will demonstrate that these parameters differentially impact on 1) the temporal compartmentalization of responding B cells within the spleen, and 2) the cellular interactions of the responding B cells with other immune cell types. As a result we will provide a mechanistic basis that will elucidate the observed differences in anti-PS and anti-protein responses. The specific aims are to: 1. Determine the nature and relationships of B cell and dendritic cell subsets, and CD4+ T cells that differentially mediate in vivo anti-PS and anti-protein Ig isotype responses to systemic immunization with intact Pn. We will utilize high speed electronic cell sorting and adoptive transfer of wild-type and genetically altered immune cells combined with ELISPOT and ELISA analyses of antigen-specific Ig isotype production to accomplish thisaim. 2. Determine the mechanism by which B cells, DCs,and CD4+ T cells differentially orchestrate anti-PS and anti-protein responses within a spatiotemporal context. We will utilize B cells from BCR knock-in mice with Ig specificity for Pn-derived PS or protein antigens and T cells from CD4+ TCR transgenic mice with specificity for a Pn-derived protein to accomplish this aim.These cells will be used to conduct in vitro functional studies and confocal microscopic analyses of splenic tissue sections post-immunization. These studies are the first to systematically determine the mechanisms that distinguish anti-PS from anti-protein responses to an intact bacterium and provide novel basic immunologic insights with direct relevanceto the development of anti-bacterial vaccines.